Core C - Cell Culture and iPS Core (CCiC)

PROJECT SUMMARY – CORE C
The Cell Culture and iPS Core (CCiC) of this program (P01) project is unique at the University of Pennsylvania
and amongst other institutions that are part of the P01. The CCiC will serve the P01 investigators and their
laboratory personnel through interrelated Specific Aims to meet their strong and compelling needs related to
murine and human esophageal primary cell cultures, establishing esophageal cell lines (normal, premalignant
and cancer cells, normal fibroblasts and cancer-associated fibroblasts), esophageal 3D culture systems
(organotypic 3D culture and 3D organoids), manipulating gene expression in cell lines (inducible
retroviral/lentiviral vectors, the PiggyBac transposon system, RNA interference, and the CRISPR/Cas9
system), and preclinical drug testing for translation to personalized medicine. The CCiC provides a rich
repository of esophageal and non-esophageal cell lines (2D and 3D) that are well annotated for identity,
passage and free of Mycoplasma infection thereby providing quality control, rigor and reproducibility.
Additionally, the CCiC generates standardized protocols and regular orientation and instruction (for all
Projects), which prove to be cost-effective measures. Furthermore, the CCiC will instruct and conduct services
related to induced pluripotent stem (IPS) cells that have been genetically reprogrammed to an embryonic stem
cell-like condition and differentiating such cells to discrete gastrointestinal cell lineages. Through its services,
technologies, quality control and time/cost-effectiveness, the CCiC advances the vision and missions of this
P01 project.

Public health relevance
PROJECT NARRATIVE – CORE C The Cell Culture and iPS Core (CCiC), Core C, provides essential, cost-effective, and high-quality services to all three projects of this P01, including generation of cell lines and three-dimensional cultures, the latter representing a highly physiologically-relevant platform translatable into personalized medicine. To this end, CCiC also houses instruments for tissue dissociation, cell culture, and genetic and pharmacological modifications of cells. Ultimately, the goal of the CCiC is to advance research for all P01 investigators.